Cancer Cell Biology (CCB) Research Program

ABSTRACT
The mission of the Cancer Cell Biology Program (CCB) is to fulfill the promise of personalized cancer therapy
by elucidating the critical signaling and metabolic networks controlling cancer cell properties, employing
cutting-edge chemical biology to more effectively target rate-limiting pathways in cancer, and translating these
insights to the clinic, via improved therapies or better biomarkers. To address these challenges, CCB has
recruited multiple new, world-class investigators who critically complement existing areas of excellence and
promote high quality, collaborative research. Co-led by Alec Kimmelman MD, PhD, recently recruited as Chair
of Radiation Oncology, and Michele Pagano MD, Chair of Biochemistry and Molecular Pharmacology, HHMI
investigator, and Director of the former Growth Control Program at PCC, CCB is a multi-disciplinary team of 49
members and 3 associate Members from 15 departments at NYU School of Medicine (NYUSoM) and the NYU
Department of Chemistry, who perform basic, translational, and clinical research. This highly restructured
program retains select members from the former Growth Control and Stem Cell programs, incorporates several
members from the former Breast and GU programs, and has a substantially re-focused agenda. Research is
now organized around three complementary thematic aims: Aim 1) To identify regulatory mechanisms for key
cancer-relevant genes that confer selective dependencies in human tumors; Aim 2) To delineate how
metabolism is reprogrammed in cancer and discover new metabolic vulnerabilities; Aim 3) To use structural,
chemical, protein engineering and pharmacological approaches to target cancer cell dependencies for
therapeutic benefit. Program members have >$17.2M in cancer-related funding, including $6.3M in NCI grants,
$8.1M in other peer-reviewed funding, and $2.8M in non-peer reviewed support. Members are highly
productive and collaborative. During this funding period, we published 604 papers, many in high-impact
journals, with 11% intra-programmatic, 32% inter-programmatic and 27% inter-institutional (NCI-CC)
publications. CCB contributed key new insights into our basic understanding of signaling and metabolic
vulnerabilities in genetically defined cancer subtypes, uncovered new molecular targets, and designed,
developed and/or tested new therapies in investigator-initiated trials (IITs) and elucidated their mechanism of
action or resistance. CCB promotes the PCC mission by: (1) producing innovative, high-impact science that
reveals new therapeutic targets in cancer cells and their microenvironment; (2) discovering new cancer drug
molecule candidates; (3) accruing patients to high-impact, high-content clinical trials; and (4) developing
sophisticated technologies beyond the reach of individual investigators via the new PCC Biologics Initiative and
Developing Metabolomics shared resource. There is a particular focus on cancers impacting our catchment
area (lung cancer, pancreas cancer, triple negative breast cancer and prostate cancer), a strong commitment
to translation and a rich portfolio of bench-bedside-bench activities.